ANTI-NEPHROPATHIC EFFECTS OF CHRONIC INTERMITTENT INTRAVENOUS INSULIN THERAPY

To assess the effect of chronic intermittent intravenous insulin therapy for treating nephropathy in Type I diabetic patients as compared to traditional treatment.